Cellular senescence in the pathogenesis of benign prostatic hyperplasia and associated lower urinary tract dysfunction

PROJECT SUMMARY/ABSTRACT
Benign prostatic hyperplasia (BPH) and associated lower urinary tract symptoms (LUTS) is a prevalent condition
among aging men, affecting ninety percent of all men above the age of eighty years. The causes of BPH/LUTS
are considered multifactorial although it is known that aging is the number one risk factor for development and
progression of disease. Despite initial effectiveness, current medical management strategies that target smooth
muscle dysfunction or prostatic proliferations often fail to effectively manage disease progression, leading
patients to seek out invasive surgical interventions. A key factor hypothesized to contribute to BPH/LUTS
progression is prostatic fibrosis, which current therapies do not address. Age mediated cellular senescence,
defined as a stable and irreversible cell-cycle arrest, has been implicated in the dysregulation of prostate tissue
homeostasis. I hypothesize that age-mediated cellular senescence within the prostate drives prostatic
fibrosis and therefore contributes to the development of lower urinary tract dysfunction (LUTD) and BPH.
Our study aims to determine the role of senescent cells in BPH/LUTS pathogenesis and evaluate the therapeutic
potential of senescent cell elimination. I aim to evaluate this hypothesis using clinical human prostate tissues
and mouse models for BPH/LUTS. Specifically, I will investigate whether the degree of lower urinary tract
senescence correlates with dysfunction and if targeting p16-positive senescent cells can decrease prostate
fibrosis and improve urinary health. Additionally, I will examine the relationship between senescent cells and
prostatic fibrosis in human BPH tissues and assess the impact of pharmacologically eliminating senescent cells
using a clinically translatable senolytic dasatinib and quercetin (D+Q) in aged mice. This research will provide
insights into the role of cellular senescence in BPH/LUTS and explore novel therapeutic approaches to improve
patient outcomes. The extensive resources at the University of Wisconsin School of Medicine and Public Health
create an optimal setting for the successful execution of this proposed work. Completing this study will foster the
development of crucial experimental, mentorship, communication, and clinical skills, facilitating a smooth
transition to a career as an independent researcher and surgeon-scientist.

Public health relevance
PROJECT NARRATIVE Benign prostatic hyperplasia (BPH) is the most common cause of age-related lower urinary tract dysfunction in men worldwide, resulting in significant morbidity, mortality, and major burden on global healthcare systems. We aim to investigate the role of senescent cells in the development of fibrosis-mediated BPH and lower urinary tract dysfunction. Understanding how aging cells contribute to prostatic fibrosis and urinary dysfunction will help identify new therapeutic targets and improve treatments for aging men, ultimately enhancing their quality of life and advancing the field of benign urological research